Colorado HNC SPORE Biospecimen/Pathology Core

SUMMARY, BPC
The Biospecimen/Pathology Core (BPC) is the central repository of specimens established to provide support to
the Head and Neck Cancer (HNC) SPORE to aid in the successful execution of the proposed studies. Through
the BPC we will establish a comprehensive resource of tissue specimens, body fluids, and tissue isolates
(DNA/RNA) that will support the SPORE and can be used by extramural investigators to improve our
understanding of the underlying mechanisms in the onset, development, and progression of head and neck
cancer and improve treatment options to aid the clinician in patient management. The main goals of the BPC
are to procure, characterize, analyze and process, and distribute specimen. The provision of these services
takes advantage of a close working relationship with the existing facilities, infrastructure, and personnel for
biobanking and histology operations of the University of Colorado Cancer Center Tissue Biobanking and
Processing Shared Resource and the University of Colorado Biorepository Core Facility. Specimens are
collected as archival tissue or SPORE trial associated specimens that are obtained under IRB approved
protocols. The BPC will also collect correlative clinical and biologic information that can be included in specimen
distributions. The BPC provides histologic interpretation, performs immunohistochemistry (IHC) and
quantification of IHC by image analysis, prepares biospecimen isolates (RNA, DNA, protein), and provides
molecular analysis on selected specimens required by the SPORE projects. This includes histologic review and
classification by up-to-date published WHO classification systems by the pathologist leadership of the core. The
core designs its activities to meet the needs of each of the SPORE projects as outlined in the proposal. In order
to meet the tissue needs and achieve the goals of the projects, the BPC collects and processes tissues in a
specific manner as determined via collaboration with project investigators. The BPC also collaborates in the
performance of project related studies in which expertise of BPC personnel can benefit study design, data
generation, and data analysis. The BPC will provide the necessary experience and expertise to be able to
develop CLIA certified testing to translate research findings into clinical utility.

Public health relevance
NARRATIVE, BPC The Biospecimen/Pathology Core (BPC) is essential to the success of the Colorado Head and Neck Cancer SPORE. The BPC is a central service that obtains tissues and information from patients with head and neck cancer. The collected tissue and information is stored and processed so that researchers have the best possible materials and information for their projects. In addition, the BPC provides unique skills and expertise in pathology and analysis technology to be successful in the execution of their projects.